Admin Core

During the past fifteen years of we have established effective administrative infrastructure to ensure efficient operation and provide multi-level support for the integrated research, training, and dissemination activities of the CFNT. Although our overall administrative framework will remain unchanged as we enter a new funding cycle, we continually strive to strengthen and further extend this framework, working in pursuit of these Specific Aims: 1, Coordinate administrative procedures to support cohesive research relationships between TRDs, CPs and SPs, and streamline CFNT operation. 2, Provide administrative support for effective training in and dissemination of CFNT-developed technologies. 3, Ensure compliance with all funding agency and institutional policies and reporting requirements by interfacing with Martinos Center and MGH administration, as well as with NIH and NIBIB program staff